Mechanisms of Translation Regulation During Stress

ABSTRACT
The dynamic regulation of the proteome is critical for cell survival and function. Traditionally, researchers have
focused on elucidating the discrete steps of protein synthesis, quality control, and degradation to understand
how the proteome is formed and maintained. Yet, a growing body of research suggests communication
between translation, quality control, and protein degradation pathways enables the cell to maintain protein
homeostasis (proteostasis). Proteostasis collapse is a hallmark of aging and aging-associated
neurodegenerative diseases, and alleles of proteostasis genes are associated with a wide range of human
genetic diseases. Therefore, understanding the mechanisms that underlie proteostasis holds promise for the
identification of novel diagnostic and therapeutic intervention strategies to improve health across the lifespan.
My research program will address how protein quality control factors interact and feedback to regulate
translation. Our overarching goal is to determine the mechanisms by which protein degradation factors
collaborate with the translational machinery to synthesize proteins. We hypothesize that the dynamic regulation
of mRNA translation requires protein quality control and degradation activities to prevent catastrophic
proteostatic collapse. This hypothesis is supported by the observations that inhibition of the ubiquitin-
proteasome system feeds back to (i) inhibit global translation activity, and (ii) impairs the dynamics of RNA-
protein (RNP) granules that sequester translationally repressed mRNAs. In the next five years, my research
group will evaluate the role of protein quality control and degradation factors in mediating protein synthesis at
the levels of translation initiation, elongation, and by facilitating the dynamic assembly and disassembly of RNP
granules. To begin to address this problem, we will answer the following questions: (1) Is translation elongation
differentially regulated during proteostatic stress? (2) What is the role of the protein quality control machinery in
mediating translation initiation and elongation? (3) What is the relationship between translation and RNP
granules? (4) What are the molecular mechanisms by which protein quality control and degradation factors
drive RNP granule disassembly? We will leverage advanced genome engineering, optogenetics, and live cell
imaging strategies to define the mechanisms that regulate mRNA translation in human cells in response to
proteostatic stressors. The outcome of this research will be a spatially and temporally defined map of the
molecular mechanisms governing mRNA translation during proteostatic stress. The impact of this work will be
in contributing to our knowledge of how proteostasis is maintained in eukaryotes and identifying novel
treatment approaches for a wide range of human diseases that arise due to loss of proteostasis.

Public health relevance
PROJECT NARRATIVE My research program aims to identify the proteins and signaling pathways that coordinate mRNA translation to prevent catastrophic proteostatic collapse. Defects in translation, RNA-protein granules, and protein degradation are associated with degenerative conditions of the nervous, muscular, and skeletal systems, cancer, diabetes, aging, and neurodevelopmental disorders. A mechanistic understanding of protein homeostasis will aid in the development of novel therapeutic strategies to improve health across the lifespan.